Regulation of the Inflammasome by Gasdermin D mRNA Chimerism

ABSTRACT
Appreciation for the complexity of RNA processing is essential for understanding regulatory mechanisms of
innate immunity. We uncovered novel splice variants that occur through the fusion of two distinct RNA transcripts
(chimeric mRNA) in murine macrophages, including a fusion transcript containing Gsdmd and Tmem106a
(Gsdmd:Tmem106a), two genes situated on separate chromosomes. Following inflammasome assembly,
triggered by microbial signals and cellular damage, gasdermin D (GSDMD) is cleaved into its active form by
inflammatory caspases. GSDMD N-terminal (GSDMD-NT) fragments oligomerize and create pores in the plasma
membrane allowing for the release of IL-1β. This often triggers inflammatory cell death but occasionally allows
for longer lasting states of pro-inflammatory cytokine release. GSDMD is essential for host defense against a
variety of bacterial pathogens but excessive inflammasome activation and GSDMD pore formation is linked to
autoinflammatory diseases, sepsis, and cytokine release syndrome. Regulatory mechanisms of pore formation,
acting downstream of GSDMD cleavage, are a topic of intensive investigation. To functionally assess the role of
Gsdmd:Tmem106a downstream of inflammasome activation, we selectively knocked-down this chimeric mRNA
using RNA interference and discovered that it is required for optimal IL-1β release. Based on our preliminary
results, this proposal will test the hypothesis that Gsdmd:Tmem106a facilitates GSDMD pore formation
and contributes to physiological inflammation. To robustly investigate the function of this chimeric mRNA
and protein, we generated two mouse models: endogenous GSDMD:TMEM106A protein tag mice (GTMyc) and
GSDMD:TMEM106A-deficient mice (GTstop). Aim 1 of this proposal will mechanistically interrogate
Gsdmd:Tmem106a function by first characterizing chimeric protein localization and interacting partners during
inflammasome activation using GTMyc mice (Aim 1.1) and secondly, by assessing GSDMD-NT oligomerization
and pore formation in GTstop bone marrow derived macrophages, as well as by using in vitro systems of GSDMD-
NT pore formation that function independently of the upstream inflammasome (Aim 1.2). As Gsdmd:Tmem106a
encodes a novel protein with a truncated GSDMD-NT, we hypothesize that it promotes native GSDMD pore
formation through direct interaction. Aim 2 of this proposal will evaluate the in vivo expression landscape of
Gsdmd:Tmem106a following systemic LPS exposure (Aim 2.1), as well as use GTstop mice to assess its
physiological role in LPS sepsis induced inflammation and death (Aim 2.2). We hypothesize that
Gsdmd:Tmem106a will be robustly expressed following LPS treatment, and that this chimeric mRNA plays a role
in exacerbating inflammation and LPS sepsis lethality, as native GSDMD has been reported to. Taken together,
this work will uncover a novel mechanism of GSDMD pore formation, and demonstrate that chimeric mRNA are
present and functional during inflammation, highlighting an entirely new class of mRNA for further exploration in
the immune system.

Public health relevance
PROJECT NARRATIVE Appreciation for the complexity of transcription and gene processing is essential for understanding the immune response. This proposal addresses the role of a chimeric mRNA, comprised of two genes fused together, as a regulator of innate immunity and inflammation. Investigating this chimeric mRNA will demonstrate the existence and functional capabilities of a previously undiscovered class of genetic material in the mammalian innate immune response and present a potential therapeutic target for some inflammatory disorders.